Integrated, cell type specific functional genomics analyses of regulatory sequence elements and their dynamic interaction networks in neuropsychiatric brain tissues

Project Summary/Abstract
We know that genetics plays an essential part in the etiology of Alzheimer’s Disease (AD), yet we do not fully
understand the complex fashion in which the many disease-­predisposing genetic loci interact. The overall goal
of our proposal is the creation of comprehensive and integrated maps of chromatin accessibility, chromosome
folding and transcriptional patterns, delineating regulatory regions in the genomes of a key disease relevant
anatomical region of adult brains, in brains from patients with AD. These maps will unmask regional or long-­
range targets of epigenomic regulatory interactions that may also be of great relevance in patients with the
same clinical phenotype.
We will use comprehensive and highly-­resolving epigenomics assays, many of which were recently developed
by us, and novel ways to integrate the data for the first time in AD relevant brain tissues. We will generate
comprehensive maps of the spectrum of organization and function of regulatory regions by integrating
complementary techniques: single-­cell ATAC-­Seq (scATAC-­Seq) to characterize chromatin openness and
HiChIP to characterize long-­range folding interactions of sorted neuronal and non-­neuronal cells, both of which
are coupled to single-­cell RNA-­Seq and long-­read RNA-­Seq for expression information, further complemented
by information about transcription factors through proteomic analysis of nuclear fractions.
These maps will then be combined with coding or non-­coding/regulatory variants in the genomic sequence in
the AD genetic candidate regions, e.g. coming from recent large GWAS and meta-­GWAS efforts, and
integrated with AD multi-­omics data sets that are based on larger numbers of specimens but were generated
with less high-­resolving methods (e.g. are not cell type specific, such as those generated by the Rush RADC
effort), which will allow us to create and validate reference maps for epigenomic marks and interactions,
determine aberrations to the reference state in patient tissue, and connect such aberrations to genetic disease
loci as well as assemble such loci into disease pathways (and likely discover additional genetic disease loci in
the process).
This project will not only greatly expand our understanding of regulatory information encoded in the human
genome and its impact on human brain function and neurodegeneration, but also produce bioinformatics tools
necessary to analyze the complex data being generated in AD multi-­omics projects.

Public health relevance
Project Narrative Genetics forms an essential part of the molecular etiology of Alzheimer’s disease, yet we do not fully understand the critical underlying mechanisms of how the many disease-associated genetic loci are related to this important pathology. The overall goal of our proposal is to create maps of how DNA in cells is organized and how stretches of DNA interact with each other in order to manage which genes are active when, in hopes of identifying key pathways that underlie Alzheimer’s disease pathology. We will use the latest technologies available to map the interactions of DNA in Alzheimer’s brains and to identify the critical pathways that are perturbed in Alzheimer’s disease, with the long-term goal to help with preventative care, early detection and intervention.